Determining the evolutionary forces shaping genotype-by-environment interactions

PROJECT SUMMARY
Understanding how evolutionary forces shape genetic variation for quantitative traits is crucial
for determining the prevalence of genetic disease in human populations. Despite numerous
examples that genotype-by-environment interactions (GxE) are important for the maintenance of
variation for biologically and medically important traits, we lack a clear understanding of the role
that GxE plays in shaping genetic variation and of the evolutionary processes that shape GxE.
In particular two broad processes could contribute to GxE: local adaptation for plastic responses
and variation in selective constraint across environments.
The proposed work evaluates the importance of these two evolutionary processes in shaping
GxE in natural populations. We will leverage large genomic, transcriptomic, and phenotypic
datasets in systems where identical genotypes can be phenotyped across multiple
biologically-realistic environments. First, we will use an extension of a test previously developed
by the PI to look for evidence of local adaptation shaping genetic variation for plastic responses,
contributing to GxE. Next, we will develop a new analysis looking for a covariance between
allele frequency and environment-specific effect sizes, consistent with the hypothesis that
variation in selective constraint shapes GxE. Finally, we will test the hypothesis that relaxed
selective constraint on rarely-expressed plastic responses limits the evolution of adaptive
plasticity by testing for evidence of reduced negative selection on genes that are only expressed
in specific environments.
Overall, this work will determine the evolutionary processes that shape GxE, filling a crucial gap
in our understanding of the maintenance of variation for quantitative traits and providing
methods that will be useful to researchers in a variety of systems.

Public health relevance
Understanding how evolutionary forces shape genetic variation for quantitative traits is crucial for determining the prevalence of genetic disease in human populations, but we lack a comprehensive view of how genotype by environment interactions (GxE) contribute to the maintenance of variation. I will address this gap by developing new methods for determining the evolutionary forces shaping GxE and applying them to large genomic and phenotypic datasets. This work will reveal the contributions of local adaptation, variation in evolutionary constraint across environments, and negative selection in maintaining GxE across natural populations.